Project 1: Immunological imprinting and immune correlates of antibody and B cell responses in natural dengue virus infections

SUMMARY
The four dengue virus serotypes (DENV1-4) cause the most important mosquito-borne viral disease of humans,
with several hundred million infections annually and almost 4 billion people worldwide at risk of infection. Yet, no
treatment is currently approved for use in humans, and vaccine development and implementation has been
problematic. The overall approach of Project 1 is to take advantage of unique Nicaraguan sample sets to address
complex questions about DENV antibody and B cell immunology in a relevant clinical and epidemiological
context. The overall hypothesis of this Project is that the magnitude and quality (i.e., repertoire and
functionality) of B cell and antibody responses are shaped by distinct structural and antigenic
characteristics of the four DENV serotypes in 1° infections and, via immunological imprinting, 2°
infections that impact clinical and epidemiological outcome. Each aim derives from advances in the current
P01. Carefully selected sequences of infections based on antigenic relatedness are analyzed using state-of-the-
art immune profiling methods at the polyclonal and monoclonal level and mapped by antigenic cartography,
antibody landscapes and antibody clustering visualizations, supported by rigorous biostatistical approaches, to
generate a deeper understanding of DENV immunological interactions with implications for public health and
vaccine development. The proposed research is possible due to the ongoing Pediatric Dengue Cohort Study
(2004-present), a community-based prospective cohort study in Managua, Nicaragua, following ~4,000 children,
now in its 20th year, and the Dengue Hospital-based Study (2005-present) in Managua, which together enable
investigation of pre-infection samples and documented sequential DENV infections. This Project is highly
synergistic with the other Projects and Cores in this P01 by sharing similar samples, methods and reagents
(Projects 2, 3; Cores B, C, D) and comparing high-dimensional immunological profiling of the B cell/antibody
response during DENV natural infections and vaccines (Project 2, Core C). Aim 1 will comprehensively define
the structural and immunological features of primary DENV infections of all 4 serotypes. Aim 2 examines how
immunological imprinting occurs from the 1° to the 2° DENV infection, leading to modulation of antibody and B
cell responses. Results from cutting-edge immune profiling methods (Core B) will be analyzed by antigenic
cartography, antibody landscapes, and serum clustering maps and compared by serotype sequence and to
vaccine responses. How these varied antibody profiles affect infection and disease outcome are addressed in
Aim 3, underpinned by specific hypotheses. Antibody repertoire will be defined at both polyclonal and
monoclonal level, using orthogonal approaches. Overall, this project will advance the understanding of
immunological imprinting in the complex DENV landscape and identify antibody/B cell correlates of protection
and risk, which should be useful for development and evaluation of dengue vaccines.

Public health relevance
Project 1: Immunological imprinting and immune correlates of B Cell and Antibody Responses in Natural DENV Infections (UC Berkeley). NARRATIVE (PROJECT 1) Dengue is a major public health problem worldwide and is complicated by the existence of four antigenically distinct yet immunologically cross-reactive serotypes. It is critical for development and evaluation of dengue vaccines, therapeutics, and diagnostics to improve our understanding of the distinct human immune responses to the four dengue viruses, immunological imprinting from the first to a second dengue virus infection, and identify what elements of the antibody/B cell response are associated with protection from or enhancement of disease. This project uses state-of-the-art high-dimensional immunological methods in the clinical and epidemiological context of our long-term studies in Nicaragua and synergizes extensively with the other Projects and Cores in the P01.